Administrative Supplement for the URI ESTEEMED Training Program at the University of Rhode Island: Enhancement of Training Outcomes and Mentor Training

PROJECT SUMMARY
The University of Rhode Island proposes to supplement the URI ESTEEMED program to improve the training
outcomes of a diverse cohort of students from underrepresented backgrounds to pursue advanced education
and degrees in bioengineering and related disciplines. The goals for this supplement are (1) to enhance the
training outcomes of URI ESTEEMED Scholars by expanding the trainee cohort to improve peer-to-peer
networking, providing additional one-on-one academic support for trainees, and increasing the opportunity for
near-peer mentorship, and (2) to strengthen mentor training in the research environment at URI by creating a
formal Inclusive Mentor Training Program, providing intensive mentorship training opportunities for faculty and
graduate student mentors, and increasing the number of training facilitators in Rhode Island. To achieve these
goals, the URI ESTEEMED program will recruit two additional students per cohort, add two undergraduate near-
peer mentors during the academic year, retain a full-time graduate assistant throughout the calendar year and
provide additional support to the Program Coordinator, PI, and Co-PI. Additionally, URI ESTEEMED personnel
will complete facilitator training in collaboration with the Center for the Improvement of Mentored Experiences in
Research (CIMER) for the Entering Mentoring and Culturally Aware Mentoring curricula, allowing them to serve
as facilitators for these trainings, and by providing these training opportunities to faculty mentors. These efforts
will be assessed through qualitative surveys conducted by the Program Coordinator and through the established
CIMER assessment platforms. In recognizing the challenges facing underrepresented students during the
college transition, this administrative supplement will thereby provide the needed support to retain trainees and
improve the development of soft and technical skills necessary for conducting research in bioengineering and
related fields.

Public health relevance
PROJECT NARRATIVE This administrative supplement will expand the URI ESTEEMED program by (1) increasing the size of the annual student cohort augment training activities and (2) strengthening mentor training through the creation of a formal Inclusive Mentor Training Program at URI. The increased cohort size will directly improve trainee outcomes through improved peer-to-peer networking, additional opportunities for near-peer mentoring, and supplemental academic support, while the Inclusive Mentor Training Program will provide sustainable and intensive mentor training with a targeted focus on supporting trainees from diverse and underrepresented backgrounds. With these additional resources, URI ESTEEMED will develop and train a diverse cohort of students with the technical and soft skills necessary to excel in advanced research programs in bioengineering and related fields.